University of Michigan MHWFAC CoFar CMC Center Application

The Mary H. Weiser Food Allergy Center and the closely associated Allergy and Clinical Immunology Division in
Medicine are submitting this application for a CoFAR CRC center. The Weiser Center has developed strong
programs in basic and clinical research in food allergy with over 20 faculty and $10M a year in external research
funding. It performs its research in the Davidson Endowed Food Allergy Research Laboratories and through the
University's clinical trials support Office (CTSO) its faculty perform clinical research and have participated in 13
of the most prominent trials of therapeutic development in food allergy. The Allergy Division's clinical operation
includes 18 allergists that see over 6,000 unique patents per year (60/40% pediatrics-adult) with food allergy
diagnoses. Our proposal under Subsection B involves a new diagnostic approach for food allergy.
Transepidermal water loss (TEWL) provides a potential approach to monitor physiological allergic reactions to
food during food challenges to avoid the induction of anaphylaxis. TEWL is an established measure of skin
barrier permeability that quantifies water efflux from the epidermis (units are g/m2/h). In anaphylaxis, blood
vessels dilate leading to heat and water loss, and recent data suggests that the extravasation of serum fluid and
proteins is proportional to the severity of allergic reaction. Our group has shown that real-time TEWL rises prior
to clinical evidence of anaphylaxis and correlates with biochemical markers of anaphylaxis. We hypothesize that
TEWL-based stopping rules can predict OFC reactions for any food and reduce the rate of OFC anaphylaxis
while improving OFC accuracy. We propose to initiate a multi-site clinical trial in a diverse cohort with OFC for
the major food allergens in the US to definitively assess TEWL's capacity to predict anaphylaxis during OFCs.
Finally, under Subsection C we will examine the relationship between food allergy and atopic dermatitis, two
disorders that share numerous genetic and environmental risk factors as well as pathogenic features. While the
importance of epithelial barrier dysfunction in food allergy pathogenesis has been recognized, genome-wide
association studies (GWAS) have identified only a limited number of food allergy risk genes, and our
understanding of the shared genetic underpinnings of these disorders remains limited. We propose to access
multiple genomic databases (covering >30,000,000 variants and >750,000 distinct individuals) to test the
hypothesis that a shared permissive genetic signature involving epithelial skin barrier-related genes underpins
atopic dermatitis and food allergy predisposition. We propose to 1) Deploy the above datasets for GWAS
analyses in atopic dermatitis and food allergy separately followed by a trans-disease meta-analysis with
Mendelian Randomization studies to define novel risk loci for each disorder and the directionality of each SNP's
effects between diseases; 2) Interrogate known and newly-discovered SNPs in food allergy and atopic dermatitis
with eQTL studies to determine the character and differential degree of contribution of each SNP to each
disorder. This will help clarify the important genetic relationship between these two diseases.

Public health relevance
Project Narrative The Mary H. Weiser Food Allergy Center and the closely associated Allergy and Clinical Immunology Division in Internal Medicine are submitting this application for a CoFAR clinical research center. The application is in three parts: Part A describes the extensive clinical/clinical research capabilities of the Center. Part B outlines a consortium-wide study project that investigates a new and potentially safer way to diagnose food allergy. Part C describes a local study that seeks to evaluate the unique genetic basis for the closely related disorders of food allergy and atopic dermatitis.